Tuning Mitotic Kinesins Through Motor Domain Post Translational Modifications

PROJECT SUMMARY
Many mitotic kinesins play multiple roles in mitosis—each likely requiring distinct mechanical behavior.
This multi-functionality implies that cells need to be able to “fine tune” these motors. We propose that post-
translational modifications (PTMs) of the motor domain (MD) of mitotic kinesins serve this role. These
PTMs are found in many mitotic kinesins and they cluster in structures that form an allosteric pathway
which couples nucleotide and microtubule binding to movement. In this proposal, we will apply a
combination of transient kinetics, single molecule mechanics, and cell biology to examine how MD PTMs
affect three multifunctional kinesins—Kif11, Kif18A, and Kif22. Results of these studies should allow us to
develop an integrated model for how cells modulate their kinesins to meet diverse needs.

Public health relevance
PROJECT NARRATIVE The ability of mitotic kinesins to serve multiple roles implies that cells must be able to tune the output of these motors to respond to varying physiological demands. In this application, we propose that motor domain post translational modifications serve this need, and using a combined biophysical and cell biological approach, we will investigate how this works.